Determining the impact of ultra-small SIV reservoirs on sustained ART-free remission

Abstract/Summary
Antiretroviral therapy (ART) effectively controls HIV replication, but it is not a cure. Therefore, considerable
efforted is devoted to developing cure regimens that reduce viral reservoirs and boost antiviral immunity.
These interventions seek to permit people with HIV (PWH) to stop ART and durably control HIV, inducing
sustained ART-free remission. However, the virologic and immunologic determinants of ART-free remission
are poorly understood. One of the enduring questions for HIV cure research is how far interventions must
reduce viral reservoirs to attain clinically relevant periods of ART-free remission. The reservoir size at ART
termination is anticipated to affect the time to viral rebound (TTR) and the capacity of antiviral immune
responses to control virus replication. Yet, the association between reservoir size and TTR is unknown, and
the immunologic basis of post-treatment viral control (PTC) is unclear. Nevertheless, it is challenging to
address these fundamental questions in human clinical trials due to variability in patient groups and difficulty
quantifying extremely small viral reservoirs in vivo. As a result, mathematical models have been developed to
help guide and interpret HIV cure studies. These models agree that extremely small viral reservoirs are
essential for HIV remission but differ in how remission can be achieved.
Thus, to address these enduring questions, we developed a simian immunodeficiency virus (SIV)/rhesus
macaque model that precisely sets the size of latent reservoirs in vivo. To do so, we infuse defined numbers of
autologous in vitro generated SIV latently infected cells into ART-treated, SIV-naïve rhesus macaques. This
model provides a level of precision and consistency in reservoir sizes that is difficult for other SIV models to
match. Further, establishing reservoirs with genetically barcoded SIV permits stopping ART and determining
TTR and the number of reactivating viruses. Therefore, we propose using this novel latency model to
determine how progressively smaller SIV reservoirs affect TTR and PTC in the presence or absence of
antiviral immunity.
Specific Aim 1: Determine the TTR for defined SIV viral reservoirs. The goal of this Aim is to determine the
TTR for increasingly small viral reservoirs in the absence of antiviral immunity.
Specific Aim 2: Determine the impact of viral reservoir size and antiviral immunity on TTR and PTC. The
goal of this Aim is to determine if latent reservoir size affects the ability of antiviral immunity to control
infection after treatment interruption.

Public health relevance
Project Narrative An essential question for HIV cure research is how small HIV reservoirs must be to achieve ART-free remission. In this study, we use a unique monkey model to precisely establish progressively smaller viral reservoirs to determine their effect on attaining ART-free remission.